Increasing the Pipeline: Latino Training Program for Cancer Control Research

DESCRIPTION (provided by applicant): The goal of this program is to increase the proportion of Latinos in cancer control research, particularly in the Southwestern U.S., by establishing a Latino Training Program for Cancer Control Research (LTPCCR) that will motivate Latino master's-level students and health professionals to complete doctoral programs and careers as cancer control researchers. The LTPCCR is modeled after an evidence-based training model entitled, Minority Training Program in Cancer Control Research (MTPCCR) that targeted a spectrum of ethnic groups in California. Specifically, the LTPCCR will recruit an annual cohort of 20 Latino master's-level students or master's-trained health professionals. An innovation of the LTPCCR is that it targets a single ethnic minority - Latinos/Hispanics who will come from the Southwestern U.S. and Oklahoma. It will provide four interventions along the pipeline from masters-level to doctoral-level training, including: a) a Summer Institute for all participants, b) 9 annual paid summer internships in cancer disparities research (Y2-5), c) 3 annual Doctoral Application Support Awards and d) a Doctoral Student Retreat. Lastly, it will demonstrate an enrollment rate in doctoral programs that exceeds Latino enrollment achieved by the previous MTPCCR. We anticipate a minimum annual Latino enrollment of at least 15% (a 33% increase over that achieved by the MTPCCR). Additional we expect at least 50% of doctoral students reporting cancer control as their research focus and the majority of doctoral students indicating that the Texas program had a strong positive influence on these academic goals. Other benchmarks for success include a significant increase in self-efficacy and in participants' intention to apply to a doctoral program after attending the Summer Institute; and a minimum of 65% of participants rating each session as excellent.

Public health relevance
PUBLIC HEALTH RELEVANCE: Despite private and governmental support for programs that encourage Latinos to move through the pipeline from high school to college to research in basic sciences and medicine, there has been little investment in the social and behavioral sciences that send cancer control researchers out into communities to conduct epidemiologic, communication, and behavioral research. The goal of this program is to address these disparities by increasing the proportion of Latinos in cancer control research, particularly in the Southwestern U.S. Despite private and governmental support for programs that encourage Latinos to move through the pipeline from high school to college to research in basic sciences and medicine, there has been little investment in the social and behavioral sciences that send cancer control researchers out into communities to conduct epidemiologic, communication, and behavioral research. The goal of this program is to address these disparities by increasing the proportion of Latinos in cancer control research, particularly in the Southwestern U.S. __SpecificAimsTextDelimiter__ Title: Increasing the Pipeline: Latino Training Program for Cancer Control Research (LTPCCR) SPECIFIC AIMS The race/ethnic distribution of populations who bear the greatest burden of cancer is not reflected in the demographics of scientists who seek to eliminate these disparities. For many cancers, there is excess incidence and/or mortality among the poor and minorities including Latinos/Hispanics (1-7). Though they are the fastest growing ethnic minority in the U.S., Latinos contribute the smallest proportion of U.S. public health doctoral students - the primary source of cancer control researchers (9, 10, 39). In public health, Hispanics are the only ethnic group with a much higher representation among master's students (10.2%) than among doctoral students (5.7%) (39). Also, even though there has been extraordinary private and governmental support for programs that encourage Latinos to move through the pipeline from high school to college to research in basic science, engineering, and medicine, there has been little investment in the social and behavioral sciences that send cancer control researchers out into communities to conduct epidemiologic, communication, and behavioral research. The overall goal of this proposed program is to address these disparities by increasing the proportion of Latinos in cancer control research, particularly in the Southwestern U.S. Dr. Amelie Ramirez, Professor and Director of the Institute for Health Promotion Research at The University of Texas Health Science Center at San Antonio (UTHSCSA) proposes to set up a Latino Training Program for Cancer Control Research (LTPCCR) in an effort to motivate Latino master's-level students and health professionals to continue along the educational pipeline into doctoral programs and careers as cancer control researchers. The intent is to replicate and adapt an evidence-based training model developed by Dr. Rena J. Pasick at the University of California, San Francisco (UCSF). Dr. Pasick's Minority Training Program in Cancer Control Research (MTPCCR) targets the spectrum of ethnic groups in California and encourages master's-level students in health sciences to pursue doctorates and careers in cancer control research. For this proposed project, Dr. Ramirez will collaborate with Dr. Pasick to offer the California model in Texas, but with a specific focus on Latinos who make up 32% of Texas' population (9). The MTPCCR was supported by an NCI-R25 grant (1999-2001). Because of its great success, it has been refunded twice (2001-2006; 2006-2011) including a replication program at UCLA with Co-PI, Dr. Marjorie Kagawa-Singer. To date, 369 students have participated, 77 of whom (21%) have enrolled in doctoral programs. The California model has three components: 1) a five-day Summer Institute that showcases needs and opportunities for minority cancer control researchers; 2) paid cancer disparities research internships; and 3) Doctoral Application Support Awards to help offset the cost of applying to a doctoral program. Experience with the California MTPCCR has made it clear that minority students in doctoral programs need academic, financial and psychosocial counseling to ensure their successful graduation. Thus, the Texas program adds a fourth component - counseling and a doctoral student retreat. The specific aims of this proposed project are to: 1. Recruit an annual cohort of 20 Latino master's-level students or master's-trained health professionals. An innovation of the LTPCCR is that it targets a single ethnic minority - Latinos/Hispanics who will come from the Southwestern U.S. and Oklahoma. 2. Provide four interventions along the pipeline from masters-level to doctoral-level training: a) Summer Institute (all participants) - Benchmarks for success include a significant increase in self- efficacy and in participants' intention to apply to a doctoral program after attending the Summer Institute; and a minimum of 65% of participants rating each session as excellent. b) Paid summer internships in cancer disparities research (nine annually in Years 2-5). c) Doctoral Application Support Awards (three annually). d) Doctoral Student Retreat. This is an innovation of the Texas program and will include counseling on financial support, academic mentoring, psychosocial support, and career counseling. 3. Demonstrate an enrollment rate in doctoral programs that exceeds Latino enrollment achieved by the MTPCCR. Our conservative goal is an annual Latino enrollment of at least 15%, which represents a 33% increase over that achieved by the MTPCCR. Additional targets are at least 50% of doctoral students reporting cancer control as their research focus and the majority of doctoral students reporting that the Texas program had a strong positive influence on these academic goals.